Reducing Fall Risk with the use of Neuromuscular Electrical Stimulation to Maximize the Hip Abductor Muscles in Older Veterans

Falls are a leading cause of injurious death and non-fatal injuries in older adults. While fall prevention is a major
VA initiative, the current best fall preventions program only reduces falls by ~30% suggesting further research
and interventions are needed to reduce fall risk. Decreased lower extremity muscle mass and strength
contribute to balance and mobility limitations. Our recent studies show the hip abductors have a unique role in
balance and mobility function. Older adults with impaired hip abductor muscles demonstrate decreased hip
abductor strength, lower balance scores, and poor stepping mechanics when recovering from a balance
perturbation. Our preliminary results also show increased fatty infiltration of the hip abductor muscles may
contribute to poor muscle recruitment and make changing the hip abductor muscles with a traditional strength
intervention difficult. Neuromuscular electrical stimulation is one method to improve muscles in older adults,
though it is not traditionally used on the hip abductors.
Our preliminary results demonstrate that older adults who use neuromuscular electrical stimulation on their hip
abductors, in conjunction with a balance training intervention; demonstrate larger improvements in hip abductor
strength, balance, and mobility function. Our central hypothesis is that the addition of neuromuscular electrical
stimulation applied to the hip abductors during a balance intervention will result in: improved balance, larger
improvements in muscle and mobility function, and fewer falls than a balance intervention alone. In this
randomized control trial, we will determine the effects of a balance and strengthening program with and without
neuromuscular electrical stimulation on fall risk and mobility (aim 1), changes in hip abductor composition,
function, activation and gait variability (aim 2), and the retention of these changes at a six and twelve-month
follow up (aim 3). We anticipate that this patient-oriented translational research will provide the first evidence
from a large randomized control trial for the use of neuromuscular electrical stimulation applied to the primary hip
abductors as an efficacious adjunct to traditional rehabilitation programs to improve balance, mobility, and
muscle in older Veterans at risk for falls.

Public health relevance
Falls are a major health concern in older Veterans. Evidence suggests that abnormalities, related to disuse, in muscles of the hips may have a major role in fall risk. This application will use novel methods of exercise to address improving the muscles of the hips as a means of reducing falls. If successful, this application will provide new practical methods to improve balance and reduce falls by improving the hip muscles in older Veterans.